Novel Sheet-Membrane Dialyzer for Wearable Hemodialysis

Abstract
More than 520,000 patients with End Stage Renal Disease (ESRD) underwent routine dialysis in the US in 2017.
Conventional hemodialysis (HD) uses floor-standing instruments, which contributes to the dominance of center-
based dialysis for the HD delivery space. Wearable HD systems could be employed to improve clinical outcomes
and quality of life for patients with ESRD by enabling continuous dialysis. Wearable HD also enables frequent
dialysis on a flexible treatment schedule. While there are potential benefits of more frequent dialysis, this comes
at a cost of increased burden on lifestyle, risks of access malfunction, and health care costs. Also, episodic
treatments provide insufficient time to remove large toxins (small diffusion coefficients) and protein-bound toxins.
The barrier is the size of the current membranes which are bulky and not easily integrated into a wearable system
and require large amounts of extracorporeal blood flow to achieve appropriate toxin clearances. Achieving
significant improvements will require highly efficient membranes that enable prescribed toxin removal in small
device formats.
Our group has developed a variety of ultrathin (< 100 nm) nanoporous, silicon-based membranes and have
established their value in improving the efficiency and precision of molecular separations. Because
nanomembranes are 100 to1000 times thinner than conventional hemodialysis membranes, we hypothesize
their ability to reduce the format for hemodialysis by orders of magnitude. We have recently developed a lift-off
technique to produce sheets of nanoporous nitride (NPN) membrane material separated from the supporting
silicon wafer. We propose to develop, using COMSOL Multiphysics modeling, a two-stage hemodialyzer
incorporating two NPN membrane sheets in series. The fist NPN sheet membrane (100-nm pores) will filter out
the cellular material generating plasma that will then be dialyzed by the second membrane (20-nm to 30-nm
pores). The two-filter system will be tested on the benchtop for its ability to separate uremic toxins from whole
blood and measured for hemocompatibility (hemolysis, complement activation etc.). The devices will also be
bench tested for their ability to withstand the pressures exerted by the extracorporeal blood flow and designed
ultrafiltration. The two-stage hemodialyzers will be tested in a small-animal model (male and female Sprague-
Dawley rats). We expect, based on previous clearance studies with chip-based NPN membranes, that NPN
sheet membranes can be used to construct a mechanically reliable hemodialysis device that achieves
homeostatic levels of toxins through continuous operation. By enabling effective hemodialysis is small formats,
our membrane technology will hasten the adoption of not only wearable HD therapies, but of portable and
implantable HD therapies. This effort supports the recently created “Advancing American Kidney Health initiative”
to transform how ESRD therapy is delivered.

Public health relevance
The proposed research is relevant to public health because providing a means of continuous hemodialysis is important for clinical outcomes by enabling more flexible hemodialysis prescriptions. The project will develop a robust, ultrathin, sheet-membrane hemodialyzer suitable for continuous hemodialysis using a two-filter system that will be tested on the benchtop and in a small animal model. The silicon nitride-based dialyzer will be scalable to clinical use and supports the “Advancing American Kidney Health initiative”.